Sustainable Open-Source Software Tools for Simulating Cardiac Dynamics

PROJECT SUMMARY/ABSTRACT
This project will support software development and community engagement for the CARDINAL open-source
software infrastructure, which aims to provide a unified platform for simulating all major aspects of cardiac function.
The prevalence of cardiovascular disease continues to drive research studies, with methodologies and scales
ranging from wet-lab experiments and animal studies to large-scale clinical trials. While these experimental
research approaches provide powerful tools for interrogation, yielding critical insights into cardiac function and
disease, in silico computational models provide a critical resource for integration, enabling the synthesis of
complex, multifaceted data into a predictive physics-based framework. Given the complex etiology of disease
and variability in clinical measurements, distilling this information to identify the optimal approach to personalized
treatment remains a significant challenge. Predictive computational models of the heart, capable of capturing
all critical aspects of cardiac function, serve as powerful synergistic tools that can assimilate clinical information
and drive predictive studies of heart function in response to treatment. A core challenge, however, remains that
effective development of cardiac computational models is hindered by the lack of available tools, forcing modelers
and researchers either to limit the scope of their studies or invest significantly in infrastructure development.
Indeed, although substantial scientific, engineering, and medical research has gone into modeling cardiac
dynamics, no open-source simulation frameworks currently provide integrated modeling capabilities addressing all
major aspects of heart function. The absence of comprehensive, open-source simulation tools addressing
the entire spectrum of heart function poses a significant barrier to advancing cardiovascular research.
The CARDINAL software framework aims to address this critical gap in the research software ecosystem. This
software development project specifically focuses on performance enhancement, containerization, and community
engagement activities that are aligned with the Building Sustainable Software Tools for Open Science (RFA-OD-24-
010) program. Aim 1 will optimize the computational performance of CARDINAL to enable scalable and efficient
simulations of cardiac dynamics by enhancing core modules and integrating performance portability libraries. Aim
2 will improve the portability and ease of deployment of CARDINAL across diverse computing environments by
developing containerized versions and providing pre-compiled binaries for major operating systems. Aim 3 will
foster community engagement and sustainability of CARDINAL by developing comprehensive documentation,
creating tutorials and example projects, establishing support channels, and conducting outreach activities to
build an active user base. Through these efforts, CARDINAL will provide a robust, scalable, and user-friendly
tool that supports advanced research in cardiovascular medicine, ultimately contributing to the development of
personalized treatment strategies and improving outcomes for patients with cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease remains the leading cause of death worldwide, motivating advanced tools to improve understanding of cardiovascular physiology and inform patient treatment. This project develops CARDINAL, an open-source software platform for simulating heart function, providing a sustainable tool for open science that supports research aimed at advancing personalized treatment strategies in cardiovascular medicine.